CANCER CENTER SUPPORT GRANT

The Center for Cancer Research is dedicated to investigations of the basic aspects of the development of cancer in mammals. These investigations are multidiscipline and have a synergic cohesion by inclusion into one physical structure. Research on the cellular, molecular and genetic basis of cancer is organized into three program areas: Cancer Immunology, Cancer Cell Biology, and Tumor Virology and Genetics. Many of the studies in the Cancer Immunology Program are concerned with genetic mechanisms underlying the diversity of immune response of both T and B lymphocytes. In addition, cellular processes controlling immunological reactions are being investigated. The Cancer Cell Biology Program has research efforts in the general area of the synthesis and modification of proteins on the surface of cells and the relationship between extracellular structure, cell morphology, and cell growth. The Tumor Virology and Genetics Program has a major emphasis on the activity of oncogenes in the development of cancer. This includes investigations of the regulations of gene expression by oncogenes, activation of oncogenes and development of methodologies for genetic analysis of human diseases.